DSPP signaling in dentinogenesis

Project summary
One of the most important goals of dentistry and the NIDCR/NIH is to generate a whole “Bio-
Tooth”. Dentin is a critical structural component of tooth. Although it has made great progress of
dentin development benefit for numerous hereditary syndromes and chromosomal anomalies,
many gaps have been remained. Understanding signaling pathways of dental mesenchymal
lineages and dentin formation would provide an avenue for repair and regeneration of dentin.
Dentin sialophosphoprotein (Dspp) is highly expressed in odontoblasts and dentin and processed
in to dentin sialoprotein (Dsp) and dentin phosphoprotein (Dpp). Dsp and Dpp mutations are
associated with dentinogenesis imperfecta (DGI), which is the most common dentin genetic
disorder.
Our long-ranged goal is to elucidate the biological mechanisms controlling dentin formation, which
will fill a key gap of knowledge leading to dentin regenerating. The objective here is to define the
signaling pathways essential for dentinogenesis. Our central hypothesis is that the novel control
mechanisms, in which the several signals among Bmp2-pAkt-pErk-Dlx3-Sp7-Gcn5-Dspp as well as
Dsp-integrin β6 and Dsp-occludin play synergic roles in controlling dentin formation. The
hypothesis is based on our strong preliminary data produced using both global knockout (KO) and
conditional KO (cKO) mouse models as well as in vitro cellular and molecule approaches. Three
Specific Aims are proposed to test this hypothesis: 1). to determine Bmp2 signaling in Dspp
expression and dentin formation. Bmp2 signal plays functional roles: Dspp expression via up-
regulation of Bmp2-pAkt-Erk-Dlx3-Sp7-Gcn5G signaling pathways. 2). to rescue dentin formation in
Bmp2 KO mice by overexpression of Dspp gene. Due to dramatically decrease of Dspp expression
and dentin defect in Bmp2 KO mice, the hypothesis is that Dspp overexpression in Bmp2 KO mice
is able to rescue dentin formation. 3). to determine Dsp signaling in dental mesenchymal cell
differentiation and dentin formation. Dsp is processed by MMP9 into active fragments, which as
ligands bind to cell membrane receptors, integrin β6 and occludin. The Dsp-β6 complex positively
stimulates Dspp expression and odontoblast homeostasis through up-regulation of Smad1/5/8
signaling. Dsp-occludin signal enhances phosphorylation of focal adhesion kinase (FAK),
promoting dental mesenchymal cell differentiation. The proposed research is innovative because
each step of transcription, posttranslational processing and signaling transduction of Dsp/Dspp is
necessary for the formation of healthy dentin. Such knowledge will advance our understanding of
the pathogenesis of inherited disorders that threaten the structural integrity of dentin and provide a
potential clue for treating dental diseases and dentin regeneration.

Public health relevance
Project narrative Dentinogenesis imperfecta (DGI) is the most common disease affecting the dentition with an estimated incidence between 1:6,000 and 1:8,000 in population. Dentin sialophosphoprotein (Dspp) is the most abundant non-collagenous protein in dentin and this gene mutation causes DGI-II, DGI-III and dentin dysplasia type II (DD-II), the most common dentin hereditary disorder. Teeth with Dspp mutations display tooth attrition, widened predentin, thin dentin and enlarged dental pulp chambers with obliterated pulp chambers, affecting quality of people life. Also, dental caries is the most common dental disease and untreated carious cavities have a significant impact on the general health of people and on the social and economic well being of communities.This reseach proposal will test a novel way to facilitate dental mesenchymal cell differentiation and dnetin formation. Specically, we plan to use genetically engineered mouse models combined with dental mesenchymal cell lines to study siganling pathways during dentinogenesis. The accmplishment of this project will have a broad impact on dentists to use the new technique for repair and regeneration of dentin in the future.